Tau regulation by METTL14-mediated RNA m6A modification in Pick's disease

PROJECT SUMMARY/ABSTRACT
Tauopathies are a group of neurodegenerative diseases that are histopathologically characterized by
abnormal accumulation and aggregation of tau in human brains. In addition to dysregulation of tau post-
translational modifications and other causes of tau protein pathogenicity, abnormal tau mRNA metabolism is
believed to play an important role, although the underlying mechanism remains elusive. N6-methyladenosine
(m6A) methylation of RNA is the most prevalent, abundant and conserved internal modification in eukaryotic
RNAs and it influences fundamental aspects of RNA metabolism including degradation, translation, splicing,
and nuclear export. While RNA m6A dysregulation is implicated in the neurodegenerative diseases, the
potential role of RNA m6A dysregulation in Tau mRNA metabolism and tauopathy in neurodegeneration has
never been investigated. Our group reported that neuronal m6A reduction contributes to neurodegeneration
in Alzheimer’s Disease (AD) by affecting CCND2 mRNA stability and inducing abnormal cell cycle events. In
our pilot study, we noted that Tau mRNA contains m6A modification sites. Importantly, we found decreased
neuronal m6A levels along with significantly reduced expression of m6A methyltransferase METTL14 in
brains from Pick’s Disease (PiD), a tauopathy-related neurodegenerative disease characterized by
accumulation of 3-repeat (3R) tau isoforms in pick bodies. These results suggest that RNA m6A
dysregulation may be involved in tauopathy. Along this line, we found conditional knockout (cKO) of
METTL14 leads to m6A reduction, Tau mRNA hypo-methylation, and Tau accumulation in mouse brains.
Based on these results, we hypothesize that METTL14 depletion-mediated RNA m6A reduction affects
Tau mRNA metabolism that leads to changes in splicing and tau accumulation in tauopathy. We will
determine the effect of METTL14 depletion-mediated m6A reduction on Tau mRNA metabolism by affecting
its alternative splicing and stability in primary neurons and mouse brains. A new hTau KI mouse model will
be used to test whether METTL14 cKO leads to abnormal tau mRNA metabolism and tau-related
neurodegeneration. The successful completion of this study will provide novel mechanistic insights into tau
mRNA metabolism and tauopathy. It offers a new therapeutic target of tau mRNA metabolism for tauopathy
during tau-related neurodegeneration.

Public health relevance
PROJECT NARRATIVE METTL14 depletion-mediated m6A reduction in Pick’s disease (PiD) with tauopathy and a mouse model of neuronal METTL14 cKO with Tau protein accumulation suggested a critical role of METTL14-m6A reduction in the regulation of Tau mRNA metabolism involved in tauopathy. In this application, we proposed to investigate the molecular mechanisms underlying the disturbed Tau mRNA metabolism caused by METTL14 depletion- mediated m6A reduction in neurons with a focus on mRNA splicing and stability, and determine whether METTL14-mediated m6A dysregulation leads to tauopathy and tau-related neurodegeneration in hTau KI mice.